Neuro-pharmacological Properties of Repurposed Posaconazole in Glioblastoma: A Phase 0 Clinical Trial

Project Summary
Background: We have used high-throughput drug screening to identify posaconazole (PCZ) as
a repurposed drug that can inhibit high grade glioma tumor cell growth, attributable to inhibition
of hexokinase 2 enzyme (HK2)-mediated pathways. HK2 is typically up-regulated in high-grade
gliomas (HGGs) but not normal human astrocytes. In further pre-clinical in vitro and in vivo
studies, we have shown that PCZ can down-regulate glycolysis, reduce angiogenesis, and
induce HGG tumor cell apoptosis.
Objectives: Our primary objective is to establish tumor tissue penetrance by PCZ, following
preoperative steady-state oral dosing. Our secondary objectives are to establish its neuro-
pharmacokinetics and pharmacodynamic profile. Methods: This will be a single-center, Phase
0, proof-of-concept study. Five eligible and evaluable participants, suspected of having HGGs
and requiring surgical resection on a non-emergent basis, will be enrolled for preoperative PCZ
administration. Five control subjects will also be enrolled. To achieve steady-state dosing, at
least 5 half-lives of drug are needed. PCZ dosing will be 300mg PO BID on the first day,
followed by 300mg PO daily, beginning 168-240 hours before scheduled surgery. Control
subjects will receive no drug. Surgical samples, along with blood samples, will be taken for
analysis from both contrast-enhancing and non-enhancing regions. 1-2 microdialysis catheters
will then be inserted into the tumor resection boundary. After administering the last dose of drug
the morning after surgery, collection of dialysate fluid and arterial blood will immediately begin
(Time 0). Additional samples will be collected at 15 and 30 minutes, along with 1, 2, 4, 6, 8, 18,
and 24 hours after ‘Time 0’. Control subjects will also have catheters implanted for
measurement of lactate and pyruvate. Mass spectrometry will be used to assess for
concentration of drug, lactate, and pyruvate in tumor tissue, dialysate fluid, and blood. HK2
activity assay, TUNEL staining, and Ki67 index will be used to study pharmacodynamics.
Long-term objectives and potential impact: Demonstration of PCZ accumulation of ≥500ng/g
of tumor tissue in ≥2 of 5 participants would warrant further investigation into its role in HGGs.
Evidence of associated anti-tumor effect would warrant a Phase II trial to assess tumor
response and survival, while signal for biological effect in a sub-set of patients but lower than
expected intra-tumoral drug concentrations would warrant a Phase I dose-escalation trial.
Establishment of the neuro-pharmacokinetic parameters of PCZ in individuals with HGGs would
provide valuable information toward the design of either a Phase I or Phase II trial.

Public health relevance
Project Narrative Posaconazole is currently used to treat fungal infections and we now have good laboratory and mouse results that it may work against high-grade gliomas too. These tumors are deadly and we have no cure but developing new drugs takes a long time and is a tremendous economic burden for researchers, the government and the pharmaceutical industry. Given how urgently we need better treatments, demonstration that this drug can penetrate tumors cells and inhibit their growth, would lend support for testing it in a larger group of patients with these tumors to establish whether we can improve patient outcomes.